URINARY FREE CORTISOL AND ITS METABOLITES

To assess urinary free cortisol and cortisol metabolites in preterm infants and compare these findings with normal terms neonates to see if they are substantially decreased or absent.